U-RISE at California State University San Bernardino SUPPLEMENT

Abstract
The mission and long-term goal of the California State University, San Bernardino (CSUSB) U-RISE Program
is to increase the diversity of the biomedical research workforce through the mentoring and training of
undergraduate students especially from underrepresented (UR) groups. The proposed U-RISE program will
accomplish this goal by 1) providing support to keep UR students in STEM majors through tutors and
supplemental instruction for gateway science courses and faculty and peer mentoring; and 2) motivating
students to pursue careers in biomedical research through authentic research experiences on the CSUSB
campus and at research intensive campuses. CSUSB is well positioned to accomplish this goal as it has a
diverse student body, a strong institutional commitment to student success and undergraduate research, and
number of faculty mentors with experience with including undergraduates in their research.

Public health relevance
Narrative The future of the nation's biomedical research workforce depends on the continued development of well- trained undergraduates who seek Ph.D. degrees in the biomedical and behavioral sciences. The next generation of researchers will increasingly be made up of underrepresented students who historically have not pursued such career goals. This project seeks to attract and prepare such students to meet this national need.